PRODUCTION OF HYBRIDOMAS

Hybridomas are being produce which secrete monoclonal antibodies of defined antigen specificity. Hybridomas have been produced against the FC epsilon receptor of mast cells and to human IgE. These monoclonal antibodies are being used for biochemical and biological studies.